Administrative Core

The goal of the Administrative Core is to provide: 1) leadership for the research base of the proposed CCMBM; 2) focused development and implementation of the Center Mission; and 3) coordination and integration of the Core Center activities. The Administrative Unit will consist of a Director (Lotz) and Associate Director (Nissenson) who are assisted by an Internal Executive Committee and an External Advisory Board. Collectively, this group will oversee the operations and fiscal management of the research cores and implement the Pilot/Feasibility Grant Program, the Tool and Technology Grant Program, and the Enrichment Program.

Public health relevance
The rationale for the Administrative Core is to create an infrastructure for leading the CCMBM program. This Administrative Unit is responsible for implementation, oversight, and reporting of all proposed CCMBM activities.